Characterizing functional translation in putative 'noncoding' regions of a genome

ABSTRACT
It is fundamentally important to understand how functional information is encoded by a genome. Characterizing
these functional elements can bring novel mechanistic insights into biological processes ranging from normal
development to disease progression. I developed a computational algorithm to analyze ribosome profiling data,
and unexpectedly revealed thousands of short open reading frames (sORFs) encoded by putative ‘noncoding’
regions, including lncRNAs, pseudogenes, and 5’UTRs. Some of the sORFs are conserved across species,
suggesting biological importance. My results together with several other genetic studies in model species have
opened up a research frontier to study the biological roles of sORFs encoded in a genome. Here I propose to
use integrated computational and experimental genomics approaches to systematically characterize biological
functions of sORFs. First, we will study basic principles driving sORF conservation and expression across
eukaryotes. Second, we will study the stability and degradation pathways of sORF-encoded micropeptides. Third,
we will examine the importance of sORFs for regulating cell proliferation. Finally, we will study the functional
roles of sORF translation in regulating RNA stability. Taken together, our study will shed light on the functional
characterization of the newly identified translated regions in a genome and provide novel insights into the
interplay between RNA translation and genome evolution. Our findings will have far-reaching implications for the
molecular understanding of translational control and peptide functions underlying development and diseases.

Public health relevance
PROJECT NARRATIVE The proposed study is to use integrated experimental and computational genomics approaches to characterize the functional roles of newly identified short open reading frames (sORFs) in cells. The work will reveal basic molecular mechanisms mediating sORF expression and conservation, as well as the tight coupling between sORF translation vs. other layers of peptide and RNA metabolic processes.